Precision Medicine for the Peripheral Nervous System Disorder Familiar Dysautonomia

Project summary/Abstract
Familial Dysautonomia represents a rare, particularly devastating form of a peripheral nervous system (PNS)
disorder. Defective development and degeneration of the sensory and autonomic nervous system in FD patients
leads to symptoms including decreased sensitivity to pain and difficulty regulating blood pressure or heart rate.
Some FD patients can have very severe symptoms, while others have much milder symptoms. Interestingly, this
is the case despite the fact that 99.5% of all patients carry a homozygous mutation in the gene ELP1 (previously
IKBKAP). ELP1 protein is involved in transcriptional elongation and tRNA modification, amongst other functions,
and the mutation specifically affects PNS tissues. There are no approved drugs for FD available and patients’
symptoms are merely managed. There is a critical need for a deeper understanding of the mechanistic
underpinning of FD for the development of precise and effective treatments. To understand why there is this
discrepancy of severity in FD, we employed the human pluripotent stem cell (hPSC) technology and successfully
recapitulated phenotypes in vitro that captured varying disease severity seen in patients. For example,
decreased sensation of pain was captured by the development of decreased numbers of sensory neurons
derived from severe FD PSCs. This model further allowed us to identify three potential modifier mutations in
LAMB4, KIAA1211 and FAT2, an extra cellular matrix (ECM) protein, actin regulator and cadherin, respectively.
These were present in severe FD patients only and were absent in mild patients. Thus, we established the basis
for a new paradigm in FD research that FD may consist of two genetically distinct sub-diseases. In preliminary
studies, we were able to employ this model to conduct a chemical screen that allowed us to identify a compound
called genipin that was able to rescue the severe FD phenotype. Here, we propose to expand on our previous
discoveries and define the molecular mechanism behind severe FD. In Aim 1, we aim to understand the
molecular mechanism underlying severe FD. In Aim 2, we investigate the mode of action of genipin and how it
may aid us in understanding the mechanism of severe FD as well as be developed as a potential future treatment
option for FD patients. We believe our studies may enable us to move the field closer toward precision medicine
for FD patients and provide deep molecular insights into the understanding of other PNS disorders.

Public health relevance
Project Narrative Peripheral nervous system (PNS) disorders affect a large population world-wide; however, few researchers invest efforts into understanding the causes of PNS disorders, leading to very few treatments available to patients. Familial Dysautonomia (FD) is a rare, genetic and particularly devastating disorder of the PNS, where patients’ symptom severity differs dramatically from mild to severe despite the fact that they all harbor an identical mutation. This project investigates the molecular mechanistic basis of disease severity in FD, using human induced pluripotent stem cells, with the promise of attaining knowledge that will have fundamental implications for FD patients, possibly for other peripheral neuropathies, and will improve our general knowledge about the molecular underpinnings of dysfunction in the PNS.